Oklahoma ACE: Molecular Destruction of Autoimmune Disease to Aid Clinical Trail Success

Project Summary
The Oklahoma ACE (OACE) aims to understand autoimmune disease biology through interdisciplinary,
collaborative research integrating clinical and basic questions. Prior OACE work as both a Basic and Clinical
ACE has significantly advanced our understanding of autoimmune disease genetics, development, flare, and
heterogeneity. The OACE has also contributed to eight ACE trials, serving as a Protocol Chair and/or a lead
recruitment site for five while also building unique patient cohorts and data/sample collections from diverse
urban, rural, and minority communities. Through this UM1 Clinical ACE submission, the OACE strives to
deconstruct the molecular heterogeneity of autoimmune disease to implement more effective clinical trial
designs, optimize biologically relevant treatment selection, and improve disease understanding.
Our primary clinical project builds on our extensive prior work demonstrating a role for EBV reactivation
in SLE disease transition, disease activity, and activation of interferon pathways. Utilizing our innovative SLE
trial design that provides temporary steroids to allow background immunosuppressants withdrawal, we will test
the effectiveness of EBV vaccination in suppressing disease activity and interferon responses in biomarker-
selected SLE patients. Partnered mechanistic studies will test the impact of EBV reactivation on autoantibody
production and B cell and monocyte activation and function in patients. Preliminary data in our alternate
clinical project has found a critical role of the type I IFN pathway in neuromyelitis optica, a complex
autoimmune disease with up to 40% of patients have continual relapse and damage even with standard-of-
care treatment. We have found that high type I IFN signatures are associated with irreversible disability after
an NMO relapse and increased B and Th17 cell signature activation. This first-in-NMO study will assess the
effectiveness and safety of the type I IFN receptor antagonist anifrolumab in NMO. Mechanistic studies will
determine changes in type I IFN, B cell, and Th17 responses and autoantibody production. Our collaborative
project deconstructs molecular heterogeneity and associated pathogenic mechanisms of SLE. Building on
preliminary data using multi-omic machine learning to predict abatacept treatment response at baseline, we will
distinguish determinants of belimumab treatment in SLE patients initially using deep immunophenotyping,
epigenetics, and transcriptomics, evolving to include single-cell technologies as necessary, to capture the
biology that determines treatment response. New with this renewal, we propose our OMRF CAP-certified
Biorepository to serve as the ACE Biorepository Core, leveraging decades of experience as an autoimmune
disease biorepository, dedicated personnel, standard policies/procedures, and high biobanking standards. Our
Administrative Core will support an Autoimmune Disease Enrichment Program and Scholars Program and
assist with these clinical and collaborative projects. The OACE will also continue to recruit for ACE Network
trials and collaborate with other ACE Centers to advance scientific discoveries that improve patient lives.

Public health relevance
Project Narrative Autoimmune diseases afflict up to 12% of the US population and remain a common cause of morbidity and early mortality. Non-toxic, effective therapeutics often do not exist. This program focuses on identifying molecular homogeneous subsets of patients to aid trials, inform treatment and improve patient outcomes.